Disparities in Risk of Dementia among People Living with HIV using Real-World Data

Project Abstract
1.2M people are living with HIV (PWH) in the US. With advances in antiretroviral therapy, the survival of PWH
has increased; half of PWH are over the age of 50. Given the number of older PWH is steadily increasing, this
has become a new population of interest in aging research. Older PWH face a 60% increased risk of dementia
with different risk profiles for neurological disorders compared to the general population. Specifically, disparities
in dementia diagnoses and care are deeply rooted in social determinants of health (SDoH), yet, the dementia
risk in PWH has not been well-characterized considering disparities including SDoH—a growing concern in HIV-
aging research. Currently, there is no cure for dementia, thus, it is vital to develop strategies for early recognition
of dementia and provide interventions on modifiable factors early to delay its onset. Developing an early warning
system (EWS) using risk prediction models enables the detection of PWH at a high risk of dementia, supporting
timely biobehavioral interventions. However, no such EWS exists for PWH. The proliferation of real-world data
(RWD) such as electronic health records (EHRs) and claims data, leveraging artificial intelligence (AI),
particularly machine learning (ML), offers unique opportunities to generate real-world evidence (RWE) for HIV-
aging research. This proposal creates a cohort of older PWH with all-cause dementia including Alzheimer’s
disease (AD) and AD-related dementias (ADRD) using a unique RWD source—OneFlorida+ network (20M
patients from Florida, Georgia, and Alabama) integrated with both individual- (e.g., education, social cohesion)
and contextual- (e.g., neighborhood characteristics) SDoH. Built upon this unique resource, our study has two
objectives: (1) examine disparities in the risk of dementia among PWH≥50 by leveraging large-scale RWD linked
with SDoH data and (2) prototype a prediction model for an EWS that identifies PWH at a high risk of dementia.
The Specific Aims are: (1) developing computable phenotypes and natural language processing methods and
tools to systematically extract key characteristics and relevant outcomes using RWD; (2) developing ML-based
prediction models and examining disparities in the risk of dementia among older PWH; and (3) applying a user-
centered design approach to prototype an EWS for detecting older PWH with high risk of dementia. Findings will
serve as the foundation for R01 submissions focused on the expansion of EWS as an AI-driven clinical decision-
support tool optimizing early detection of PWH at a high risk of dementia and the development of biobehavioral
interventions supporting the control of ‘realistically modifiable’ SDoH factors for delay of dementia onset that can
be used in PWH’s everyday life. Mentors are committed to the candidate’s training, each providing unique
expertise to the research and training plan. This K01 application, consistent with the NIA’s mission, will support
the candidate’s development as an interdisciplinary scientist with a triple background in AI, data science, and
HIV aging research, dedicated to developing data-driven approaches based on RWE for reducing disparities and
promoting healthy longevity for older PWH.

Public health relevance
Project Narrative The project proposes to examine disparities in the risk of dementia among older people with HIV (PWH) by leveraging large-scale real-world data linked with social determinants of health (SDoH) and build a prediction model for an early warning system (EWS) that identifies PWH at a high risk of dementia considered disparities. This is a major step toward addressing the evidence gaps related to dementia in PWH, enhancing the data capabilities of a cohort of older PWH with all-cause dementia created with multi-domain infrastructure including SDoH, and establishing a prototype EWS employing machine learning risk prediction models. Our innovative EWS as an AI-driven clinical decision support tool is relevant to public health as it can have a potentially significant impact on reducing disparities and promoting healthy longevity for older PWH.